Segmented In Vitro Translation for Expanding Peptide Library Diversity

mRNA display is a method of rapidly generating large protein-peptide binding datasets and discovering de
novo peptide therapeutics. In particular, mRNA display has been the starting point for discovering several
macrocyclic peptide drugs addressing a variety of conditions: cholesterol management (MK-0616, Phase III
trials), cancer radiotherapy (RYZ101, Phase III), and myasthenia gravis (Zilucoplan, approved). Yet these
compounds all took years of additional screening to advance from mRNA display hit to a lead compound.
Creating more productive mRNA libraries that yield lead-ready hits would be of great interest for drug discovery
practitioners and patients. One key limitation of current mRNA display macrocycle libraries derives from the
method of synthesis. The precursor peptides are synthesized with two fixed residues, a chloroacetyl and a thiol
amino acid, that spontaneously react to form cycles. However, this results in libraries with zero diversity at two
positions, and therefore suboptimal hits that necessarily contain these two residues. Although variants can be
manually synthesized and tested post-selection, any synergistic effects with other ring elements cannot be
recovered. Onca Bio proposes to diversify these cyclization positions, leading to binding hits that utilize all
residues, as well as more complete structure-activity-relationship datasets for use in any optimization work that
is needed.
The work will leverage a new approach, Segmented In Vitro Translation (SIVT), that allows more flexibility to
install non-natural amino acids, including those that drive cyclization. SIVT can reassign mRNA codons to
different amino acids multiple times within a single transcript sequence; i.e., the codon table is defined locally
by position, rather than globally across the entire sequence. SIVT has been demonstrated in single sequences,
but applying it in the context of ultra large libraries will require fundamental technology development in both the
methodology of SIVT, the design of the mRNA libraries, and the non-natural substrates used. If successful, the
resulting mRNA display libraries will contain diversity at every amino acid position including the cyclization
residues, and boost the overall chemical space coverage by an order of magnitude. The ultimate measure of
library productivity will be testing the libraries in mRNA display selections against “undruggable” targets and
benchmarking against typical mRNA display macrocycle libraries. Successful execution of this SBIR phase one
effort will allow Onca to commercialize SIVT-based mRNA display for peptide discovery.
Proprietary information – Onca Bio, Inc.

Public health relevance
mRNA display has been instrumental in the discovery of novel macrocyclic peptide therapeutics including recent FDA phase III candidates for cancer radiotherapy and cholesterol management. Onca Bio is advancing peptide synthesis technology by incorporating non-natural building blocks, which can address current chemical space limitations in mRNA display libraries. This project aims to generate libraries that produce superior drug candidates and facilitate optimization of therapeutic macrocyclic peptides.